Facility Renovation and Modernization to Support A National Program on Psychiatric Biotyping Research

This is a proposal to renovate a currently-disused building to create a modern, multi-modal and inter-disciplinary clinical
neuroscience research facility at The Institute of Living (IOL) in Hartford, CT. The IOL is a venerable psychiatric institution
whose recent behavioral, clinical, and cognitive neuroscience research has attained national recognition in its efforts to
understand and better treat schizophrenia, Bipolar Disorder, depression, ADHD, autism, anxiety disorders, OCD, and
addiction. Moreover, IOL’s parent organization Hartford HealthCare (HHC) has embraced a broad biomedical research
mission across its seven-hospital network within a strategic plan to make large-scale patient care approach changes that
achieve meaningful, high-impact health outcome gains. The proposed new IOL neuroscience research facility represents a
key component of that larger strategic plan. It will centralize components of both ongoing and new IOL research programs
whose activities will promote the discovery, clinical translation, and education/dissemination of research about biological
subtypes (or “biotypes”) of psychiatric disorders at a nationally prominent level. Biotypes are biologically-defined
presumptive disease entities – sets of patient characteristics that can be used to classify individual patients into subgroups
with different etiologies or who respond to different treatments. IOL investigators have made noteworthy conceptual and
empirical contributions to psychiatric neuroscience in the past two decades by demonstrating the importance and
translational potential of such biotypes. The proposed facility will build upon this foundation of expertise by consolidating
and expanding IOL’s biotyping-relevant research resources – neuroscience equipment for highly detailed, multi-modal
research-based deep phenotyping, the IOL’s newly-established experimental therapeutics research Center, and data analysis
resources to enhance biotype discovery and translation efforts, both for individual psychiatric diagnoses and
transdiagnostically. Starting with IOL’s psychosis patient clinical services that already are being converted into research-
based clinics, a key program feature will be to systematically move select clinical programming into the newly-renovated
research building so that co-localized research and clinical resources can be optimally harnessed for the goal of generating
a national biotyping data resource, as well provide as a successful model for how to best integrate neuroscience biotyping
research into clinical service delivery. Our goal is for this dedicated facility-based research approach to lead the field over
the next decade in making great leaps forward in discovering effective ways to personalize medicine for more successful
21st century psychiatric care. The proposed 18,886 SF building design vision epitomizes the overarching goal of a facility
that not only serves the primary goal of neuroscientific research excellence, but also will help meet our institution’s strategic
goals to improve patient access to innovative and experimental treatments, to enhance community engagement, and to
deliver the most effective, cutting-edge professional education in psychiatry. Due to the ambitious construction scope, and
reflecting the institution’s dedication to the high promise of the program mission, HHC has committed to cost sharing to
ensure successful completion of the construction project.